FATE OF TOXIC CHEMICALS IN HEPATOCYTE AND HEPATOMA CELLS

Conjugation of potentially toxic electrophilic compounds by glutathione (GSH) is a major function of the mammalian liver and a significant mechanism of cellular defense against many hepatotoxic environmental contaminants. Acute depletion of GSH presents a clear threat to the organism by alteration of the GSH/GSSG ratio, the NAD(P)+/NAD(P)H ratio and the cytotoxic events associated with oxidative challenge. Chronic depletion of GSH due to protracted exposure to GSH depleting agents through air and water contamination presents a different set of toxin related challenges induced by the continuous depletion of GSH and the presence of elevated intracellular levels of the GSH conjugate. Resynthesis of GSH is limited by cysteine concentration. The mechanism by which cysteine is supplied varies between cell types; some dependent on dietary absorbtion, some synthesizing cysteine from methionine, while others are proposed to depend on recovery of cysteine by degradation of GSH by Gamma-glutamyl transpeptidase. The proposed research will examine the effect of GSH depletion by diethylmaleate, ethacrynic acid, t-butylhydroperoxide, and 2,3,7,8 tetrachlorodibenzo-p-dioxin (TCDD), chemicals representative of the major class of xenobiotic GSH depleting agents, or the thiol status of selected cell types. The cells to be examined are primary cultures of rat and human hepatocytes, hepatocarcinoma HR-35 cells, the nontumorigenic epithelial adult rat liver ARL-15C1 and the tumorigenic line ARL-16T2. This collection of cells presents a developmental and transformational gradient from normal to transformed lines with intermediate stages also represented. More importantly, an apparent range of cysteine recovery mechanisms is also represented, from primarily transsulfuration to a strict cysteine requirement for growth. The specific goals to be accomplished are: 1) Evaluation of the thiol status in ARL-15C1 and 16T2 cell lines. 2) Characterization of the mitochondrial pool of GSH in ARL-15C1 and 16T2 and the effect of pool depletion on toxicity. 3) Characterize the thiol status of HR-35 hepatocarcinoma cells. 4) Determine the effect of chronic GSH depletion on chemical toxicity in Gamma-glutamyl transpeptidase containing cells. 5) By cell fusion introduce Gamma-glutamyl transpeptidase into nontumorigenic cells to evaluate alterations in the thiol status. 6) Elucidate mechanism of acute toxicity of TCDD in ARL-15C1. 7) Investigate the regulation of Gamma-cystathionase activity in rat hepatocytes before and after GSH depletion. 8) Examine the thiol status of human hepatocytes and evaluate the importance of the mitochondrial GSH pool.